Baylor College of Medicine Site Consortium - Adolescent Medicine Trials Network for HIV/AIDS Interventions (ATN) Operations and Collaborations Center (UM2 Clinical Trial Optional)

ABSTRACT Baylor College of Medicine
Harris County, which includes the City of Houston, is among the 48 counties in the United States (U.S.) in
which more than 50 percent of new HIV diagnoses occur. There is an urgent need for innovative and
collaborative new approaches to HIV treatment and prevention in adolescents and young adults (AYA) in
Houston. The long-term goal of this research is to move the U.S. and Houston area closer to ending the HIV
epidemic by addressing the issues involved in successful prevention and treatment of HIV in AYA. These goals
align with Adolescent Trials Network (ATN) research objectives and Houston Consortium partnerships will
allow research to be conducted in AYA in all five priority areas of the ATN: improving HIV testing, preventing
new infections, engaging youth in care, improving treatment and treatment effectiveness, and reducing
adverse HIV health outcomes due to COVID-19. We plan to accomplish the following specific aims as a site for
HIV care, research, and prevention in AYA. Aim 1 – Conduct the Trials of the ATN as identified by the ATN
Executive Committee (EC) and Scientific Leadership Committee (SLC): Baylor College of Medicine (BCM)
ATN site has a longstanding research unit with staff with years of experience working with AYA, both in a
clinical trials settings and in the community, who are living with HIV (LWH) or are at risk for HIV. Aim 2 –
Participate in the Development of Trials: BCM's ATN Project Lead and staff have years of experience in
development and conducting of clinical trials in AYA and so will work in collaboration with the ATN Operations
and Collaborations Center (OCC) to develop and conduct the trials performed in the ATN. In addition, the BCM
Youth Community Advisory Board, (YCAB), which has had members who have been active in the ATN Youth
Advisory Council (YAC) and National CAB, Youth Experts and Advocates for Health (ATN-YEAH), will evaluate
and provide input on developing studies and provide and enhance ideas for future studies. Aim 3 – Provide
Innovation Regarding Successful Recruitment and Enrollment of Participants: As an ATN Site Consortium, we
have the structure, experience, and outreach to approach this aim at multiple levels with outreach in hard-to-
reach AYA including racial and gender minority and homeless youth. Aim 4 – Provide Sites (Texas Children's
Hospital and Harris Health Northwest and Thomas Street Health Center) as well as outreach within the
Houston ATN Consortium, local laboratory capacity, and pharmacy support in order to conduct the ATN trials
in collaboration with the OCC. Aim 5 – Continued evaluation and adjustment of Houston collaborative
consortium leadership model for meaningful and continued community engagement as reflected in ATN
research study participation of AYA at risk for or LWH. We anticipate the expected outcomes of improvements
in each ATN priority area along the continuums of HIV infection and prevention. This project is high impact
because it will provide the necessary consortium in impacted communities of AYA in a high-priority region of
the U.S. to collaborate with the OCC to make sustainable progress in reaching the ATN goals.